Integrating Genomic Risk Assessment for Disease Management in a Clinical Population

In the United States, 60% of adults have a chronic disease and 40% have two or more. Collectively these
diseases are the leading causes of death and disability, accounting for >90% of our nation's $3.3 trillion annual
health care costs. Genome-wide association studies (GWAS) have identified genetic underpinnings of disease
and enabled the development of polygenic risk scores (PRS) that may help to predict the occurrence and
progression of common diseases.

Working with the eMERGE team, we will select the fifteen diseases of public health impact. For these
diseases, we will finalize the PRS to be adopted including adaptations (if any) for various race groups, the
genotyping array, the family history (FHx) tool and key clinical variables to be used in calculating genomic risk
estimates (GRE). We will identify GRE thresholds at which genomic risk assessment (GRA) with risk reduction
recommendations (RRR) in concordance with practice guidelines. To strengthen the evaluation of race-specific
PRS, we bring an additional cohort of 30,0000 African Americans.

We will conduct a pilot ethical legal social implications study, to explore patient perspectives on use of FHx and
PRS for estimating disease risk among Alabama Genomic Health Initiative (a statewide cohort) participants.
The results will inform the development of consent, educational materials and a communication strategy to
enhance recruitment and retention of eMERGE participants.

We will prospectively recruit 2,500 patients with >75% patients from primary care, incorporate PRS, FHX and
clinical data to compute GRE for the selected fifteen diseases for all patients. For high-risk patients, where
GRE exceeds pre-specified thresholds (n~ 5000 of the 20,000 recruited across the network), deploy clinical
decision support (CDS) and present the GRA and RRR. We expect ≥50% uptake of RRRs.

We will assess whether the uptake of GRA-RRR improve outcomes. We will assess three outcomes: uptake of
GRA-RRR (implementation outcome), adherence to clinic visits (engagement outcome), and surrogates of
disease / control (clinical outcome, e.g. blood sugar, cholesterol).

Although research has identified genomic signatures of common diseases, genomic risk assessments to
identify, and if appropriate, pre-treat at-risk patients have not been implemented in clinical care. This is the vital
first step to leverage the power of genomics to prevent disease. We bring our expertise and experience to
collaborate with the eMERGE investigative team to take this vital first step.

Public health relevance
Narrative In the United States, 60% of adults have at least one chronic disease such as heart disease, cancer, and diabetes and 40% have two or more. Although research has identified genomic signatures of common diseases, these genomic risk assessments are not used in clinical care to identify, and if appropriate, pre-treat patients at high risk for developing disease. Establishing methods to implement genomic risk assessment and management in clinical care is the vital first step to leverage the power of genomics to prevent disease.